Population neuroscience of sex differences in the Alzheimer's disease biomarker cascade: The role of cerebral small vessel disease

ABSTRACT
The purpose of this proposed Mentored Research Scientist Career Development (K01) Award is to
support the Candidate’s long-term career goal of leading a research program to elucidate sex-specific
vascular contributions to AD and related dementias (ADRD) by applying the most cutting-edge assess-
ments of cerebrovascular integrity and advanced epidemiologic methods. Whether there are sex differ-
ences in the cerebral small vessel disease (cSVD)-to-Alzheimer’s disease (AD) pathophysiological cas-
cade is currently unknown. The first aim of this proposal is to test for sex differences in tissue-based
cSVD markers, Aβ, tau, and the cSVD-AD pathway. The second aim is to evaluate the role of vessel-
based cSVD markers, measured by ultra-high field MRI, in the AD cascade and whether there are sex-
related differences. To successfully achieve the Candidate’s career development goals and research
objectives, the proposed K01 Award builds upon the Candidate's training in population neuroscience
of aging and state of the art methods of ultra-high field small vessel imaging in older adults and adds
four key areas of new training in addition to career and leadership development: 1) cohort harmoniza-
tion methods; 2) causal inference methods to address external validity of highly selected study samples;
3) PET neuroimaging of AD pathology; and 4) sex and gender effects on cerebral pathophysiology of
AD. This proposal incorporates several innovations that will allow the Candidate to better assess the
importance of cSVD for sex differences in the AD biomarker cascade in the population at large: 1)
application of state-of-the-art ultra-high field MRI to obtain direct vessel measures of early cSVD and
2) use of innovative neuroimaging harmonization and causal inference analytic approaches to over-
come the “catch 22” obstacle that typical neuroimaging biomarker studies are not high in external va-
lidity, but collecting neuroimaging in large, population representative cohorts is typically not feasible.
The application is also innovative in relation to the current theoretical framework guiding AD research,
testing boundaries of the extant dynamic AD biomarker model which does not include cerebrovascular
biomarkers. Achieving these training and research objectives will support the Candidate's development
as an independent investigator and a leader in sex-specific trajectories of AD. Ultimately, the Candi-
date’s broader career goal is to develop an impactful research program which identifies sex-specific
intervention targets and improves the lives of older men and women.

Public health relevance
NARRATIVE Compared to men, late-life women are at greater risk of cerebral small vessel disease, bear a greater burden of Alzheimer’s disease, and may develop Alzheimer’s disease via different pathways. NIH has recently prioritized understanding sex differences in Alzheimer’s disease and related dementias, specifically highlighting sex in its high priority research area in epidemiology of Alzheimer’s disease and related dementias. The proposed research is relevant to public health because understanding whether cerebral small vessel disease can explain sex differences in the Alzheimer’s disease pathophysiological cascade in the population at large can provide insight into markers of target engagement and sex-specific intervention targets which could be used to reduce Alzheimer’s disease dementia.